Glucocorticoid and SGK1 regulation of CFTR in the intestine: role in diarrhea

PROJECT SUMMARY
Intestinal fluid secretion is a principal function of enterocytes and is mediated by the cystic fibrosis
transmembrane conductance regulator anion channel, CFTR. Stress and CFTR are linked to common
diarrheal diseases such as Irritable Bowel Syndrome (IBS-D) that affects 20% of the US population. CFTR is
also linked to diarrhea due to genetic, inflammatory, common E. Coli infections, and other etiologies. But how
stress exacerbates or leads to diarrhea is not understood. This proposal examines novel mechanisms that
regulate CFTR in the intestine with the aim of advancing our knowledge of gut fluid secretion and developing
new therapeutics. We have a special interest in identifying new and novel druggable targets to treat diarrheal
diseases stemming from genetic, infectious, and stress-related etiologies. CFTR is regulated by direct
cAMP(PKA) and cGMP(PKG)-dependent phosphorylation and vesicular traffic in enterocytes. This proposal
centers on a key but previously unrecognized role for glucocorticoids (GCs) and serum glucocorticoid kinase 1
(SGK1) in regulating intestinal CFTR and the potential for targeting this pathway to treat diarrhea. SGK1 is
transcriptionally regulated by glucocorticoids (GCs), mineralocorticoids, cell stress, and other factors, and
potently regulates ion transport by transcription, translation, and traffic. However, nothing is known about how
GCs and SGK1 regulate CFTR in the intestine. The hypothesis to be tested here is that GC, SGK1, and kinase
signaling pathways regulate CFTR in the intestine and can exacerbate diarrheal diseases. The hypothesis will
be tested through the following aims: (1) Determine the role of GC and kinase signaling in regulating CFTR
function, mRNA, and protein expression in the intestine. (2) Examine the role of GC and kinases in regulating
CFTR membrane traffic in the intestine. (3) Examine the role of GC-SGK1 pathways in cGMP-elicited diarrheal
diseases. These aims will be achieved by employing two animal models (SGK1 KO, and Nedd4-2KO), cultured
intestinal cells expressing endogenous CFTR, and scientific approaches including Ussing chamber
electrophysiology, in vivo trafficking assays, shRNA silencing, kinase signaling assays, mass spectrometry,
qPCR, immunoblotting and immunofluorescence staining. Collectively, these studies will break new ground
and expand our understanding of mechanisms regulating CFTR in the intestine and potentially identify novel
physiologic targets to treat CFTR-mediated diarrhea stemming from diverse etiologies.
PHS 398/2590 (Rev. 06/09) Page Continuation Format Page

Public health relevance
PROJECT NARRATIVE The secretion of fluid is a principal function of the intestine that is altered under conditions of stress, and infections to result in diarrhea. This proposal explores the cellular mechanisms responsible for fluid secretion in the intestine under the condition of stress and infections. This work will increase our understanding of how stress exacerbates diarrhea and identify targets for treatment.